Psychostimulant actions: essential role of a2-GABA-A receptors in the NAc

DESCRIPTION (provided by applicant): Human genetic studies have linked polymorphisms in the gene encoding the GABAA receptor α2 subunit, GABRA2, to substance abuse, but neuronal mechanism and brain regions involved are still unknown. Recent experimental evidence suggests that a global deletion of α2-containing GABAA receptors abolishes cocaine-induced behavioral sensitization;however, it was also reported independently that during cocaine sensitization the α2 subunit is downregulated in the nucleus accumbens. We propose to use a model system utilizing our recently developed Gabra2 floxed mouse line in which recombinant adeno- associated virus expressing cre recombinase causes a knockdown of α2-containing GABAA receptors in the nucleus accumbens in order to evaluate whether these receptors are required for cocaine sensitization and cocaine-induced conditioned place preference. PUBLIC HEALTH RELEVANCE: genetic studies have revealed that polymorphisms in the GABRA2 gene encoding the GABAA receptor α2 subunit are associated with substance abuse. The proposed project will investigate whether α2-containing GABAA receptors in the nucleus accumbens are required for the the expression of addiction- related behaviors. If it is determined that α2-containing GABAA receptors promote addiction-related behaviors, α2-selective antagonists might be useful in the treatment of drug addiction.

Public health relevance
Relevance Human genetic studies have revealed that polymorphisms in the GABRA2 gene encoding the GABAA receptor α2 subunit are associated with substance abuse. The proposed project will investigate whether α2-containing GABAA receptors in the nucleus accumbens are required for the the expression of addiction- related behaviors. If it is determined that α2-containing GABAA receptors promote addiction-related behaviors, α2-selective antagonists might be useful in the treatment of drug addiction.